NIAID Influenza Data Processing and Communication Center: Universal Influenza Vaccine Research Activities

The Influenza Data Processing and Communications Center will provide processing for data collected and generated by the NIAID Centers of Excellence for Influenza Research and Response.